Coupling Epitranscriptomics to Molecular Disease Mechanisms and Nucleic Acid Therapeutics in Persistent Residual HIV Infection

PROJECT SUMMARY
Human immunodeficiency virus (HIV) is a highly manageable infection when treated with combination
anti-retroviral therapy (cART). However, it is not yet curable and people living with HIV (PLWH) taking
cART suffer from suboptimal immune health and reduced quality of life long-term. A leading cause of
ongoing health concerns is persistent, residual infection. Persistently infected T-cells of PLWH that take
cART still produce viral RNA and proteins, as well as defective proviruses, that can chronically activate
the immune system despite undetectable viral loads. A better understanding of the biology and
metabolism of HIV RNA and gene expression in PLWH taking cART could unlock additional therapeutic
strategies to reduce viral gene products and improve quality of life.
Cellular RNA and viral RNA can be subjected to a variety of post-transcriptional chemical
modifications. These modifications modulate or fine-tune molecular interactions and thereby control gene
expression and function through RNA processing, turnover, localization, or translation. Covalent base
modification and its effects on RNA regulation at a broad level beyond the four canonical bases is often
termed epitranscriptomics. The intimate relationship between RNA modification and RNA metabolism is
becoming better appreciated. However, manipulating this process for therapeutic treatment of HIV and
persistent infection in PLWH taking cART requires a deeper understanding of HIV epitranscriptomics.
Here we propose systematic characterization and manipulation of HIV-1 RNA transcripts in model and
patient T-cells. In the R61 phase, we will utilize three powerful sequencing methodologies (total RNA-seq,
ribosome profiling, and nanopore direct RNA sequencing) to globally characterize the abundance,
processing, translation, and modification status of both viral and host RNA in T-cells during cART. These
experiments will include selection of persistently infected T-cells from PLWH taking cART. We will target
several known modifications via enzyme knockouts and nanopore sequencing. These experiments will
characterize HIV-1 RNA chemical modifications of potential significance and identify those with high a
likelihood of impacting HIV RNA and protein loads in T-cells.
In the R33 phase, we will use chemically modified oligonucleotides to alter modifications of high
interest by blocking or directing site-specific modification. This will include oligonucleotides that sterically
block modification or guide new modification, both therapeutic modalities that are maturing rapidly.
Chemically modified oligonucleotides will provide a proof-of-concept for epiptranscriptome manipulation
as a potential therapeutic approach while offering nucleic acid therapeutic candidates.

Public health relevance
Project Narrative Quality of life remains suboptimal for people living with HIV taking anti-retroviral drugs due to persistent infection and its negative impact on health. Persistent infection generates virus RNA and protein that contributes to chronic low level immune activation. This project will focus on the therapeutic potential of reducing viral RNA and protein burden by understanding and altering the chemical state of HIV RNA.